Measuring and improving specialty care coordination in VA

BACKGROUND
Fragmented health care – the splitting of a patient's care across multiple providers – increases risks of patient
and provider dissatisfaction, resource waste, and potentially devastating health outcomes. Coordinating care to
prevent these outcomes is a VA priority, and an increasing challenge as Veterans receive more care from non-
VA providers. Coordination is the organization of patient care between two or more participants to ensure
appropriate delivery of healthcare services. For specialty care referrals, which number >25 million yearly in VA,
the most direct participants are patient, specialist and PCP, the “specialty care triad”. To improve specialty care
coordination, a measure and interventions are needed that account for the experience of each triad member.
OBJECTIVES
Aim 1. 1.1. Adapt a trio of surveys designed to a) measure the experience of specialty care coordination,
and b) measure the frequency and effectiveness of specific coordination mechanisms among
patients, medical specialists, and primary care providers
1.2. Determine the psychometric properties of the survey questions on coordination (from 1.1a)
Aim 2. 2.1. Use qualitative methods to identify barriers and facilitators to effective use of 4 specialty care
coordination mechanisms that are found in Aim 1 to be both widely used and variably successful
Aim 3. 3.1. Use data from Aim 2 to develop and pilot-test an intervention to implement one or more
mechanisms to improve specialty care coordination, and evaluate it on the basis of feasibility,
acceptability, and changes in scores of survey questions about mechanisms (from 1.1b)
3.2. Examine concurrent validity of the survey questions about coordination (from 1.1a) by
comparing changes in them pre- and post-intervention to changes in existing validated scales
METHODS
In Aim 1, existing instruments will be adapted into 3 surveys to measure the experience of specialty care
coordination and the helpfulness of specific mechanisms to coordinate. Psychometric properties of the surveys
will be assessed through a national VA pilot administration. In Aim 2, semi-structured interviews will be
conducted with triad members at 8 VA medical centers, to understand the key factors to success of 4 selected
mechanisms. Data analysis will use a mixed deductive-inductive approach and be guided by the Consolidated
Framework for Implementation Research. Aim 3 will build on Aims 1 and 2 to develop and evaluate a multi-
faceted intervention that uses one or more mechanisms to improve specialty care coordination for the triad.
ANTICIPATED IMPACT
This CDA will provide a metric of success that accounts for the experience of the most direct participants in
specialty care coordination, including the patient. It will provide information about the barriers and facilitators to
success of commonly used mechanisms to coordinate specialty care. It will also result in an intervention to
improve specialty care coordination for the triad members. In future work, the survey measure 1) can be used
to evaluate and compare interventions to improve coordination, both within and outside of VA; 2) can be used
to identify which organizational features and mechanisms to coordinate care correlate with high and low
success in specialty care coordination, for each triad member; and 3) will allow examination of which aspects
of coordination, from which triad members' perspectives, are associated with which clinical and cost outcomes.

Public health relevance
Poorly coordinated healthcare is associated with patient and provider dissatisfaction, health risks, and resource waste. Coordination of specialty care is a particular challenge which is growing as Veterans receive more care from outside VA. To measure and improve specialty care coordination in VA, we must account for the perspectives of Veteran patients, referring PCPs, and specialists. I will use quantitative and qualitative methods to address this issue. I will develop surveys to measure success in coordination that include the perspective of the patient, PCP, and specialist (the “triad”); I will conduct patient and provider interviews to understand facilitators and barriers to successful coordination efforts; and I will develop an intervention to improve coordination of care for the triad that builds on existing processes. The survey, interview findings, and intervention will be used to optimize specialty care coordination in VA. They also form the foundation of future work to better understand and coordinate specialty care, and ultimately improve satisfaction, health, and costs.